Cellular protein maturation and degradation

Summary
The vast majority of the ~7,000 proteins that traffic through the mammalian secretory are modified by one
or more glycans. These alterations include the modifications of Asn (N-linked) and Ser/Thr (O-linked)
residues. Carbohydrates appended to proteins can assist with protein folding, quality control and
trafficking, or control their activity and function. In this proposal, we will study the mechanism and role of
the addition of the hexose epimers of glucose and mannose in the endoplasmic reticulum (ER).
Protein maturation is monitored by a quality control process that evaluates the structural integrity of
maturing nascent chains, and permits the passage of properly folded proteins. Alternatively, non-native
proteins are marked for ER retention so that the defect can be repaired, or if irreparable, targeted for
degradation. Calnexin and calreticulin are ER carbohydrate binding molecular chaperones that direct the
folding and trafficking of secretory pathway cargo by selectively binding to monoglucosylated side chains
on maturing proteins. Therefore, to a large extent the glucosylation state of a glycoprotein controls its
flow proteins in the secretory pathway. The glucosylation state is controlled by the UGGT family members
UGGT1 and UGGT2 that appear to selectively modify immature or non-native clients to support
persistent chaperone binding. These soluble UGGTs transfer glucose from UDP-glucose to maturing
cargo in the early secretory pathway. In the first two aims of this proposal, we will test the hypothesis that
the UGGTs are central quality control gatekeepers that control the flux of proteins through the ER by
examining their specificity and the role of reglucosylation in the cell.
The hexose epimer mannose is also added to proteins in the ER. In contrast to reglucosylation,
mannosylation involves the transfer of mannose by a membrane embedded transferase from a dolichol-
P-precursor directly to Ser/Thr residues to form an O-glycosidic bond. There are two families of putative
O-mannosyltransferases that reside in the ER membrane in mammalian cells, the POMTs (POMT1 and
2) and the recently discovered TMTCs (TMTC1-4). Little is known about their mechanisms of action and
the function of adding a mannose to maturing proteins in the ER. We have recently found that TMTC3 is
involved in the O-mannosylation of E-cadherin and that E-cadherin’s O-mannosylation aids in cell
adhesion and neurodevelopment. Mutations in TMTC3 are associated with the neurodevelopment
diseases, underscoring the biological significance of this post-translational modification. Specific aim 3 is
to understand the mechanism and significance of O-mannosylation in the ER. The long-term goal of this
project is to understand the process of hexose addition including the substrate selection and modification
steps, and how these post-translational modifications control the trafficking and functions of proteins.

Public health relevance
Project Narrative The goal of this project is to understand how protein maturation, quality control and function in the cell is directed or regulated by the addition in the endoplasmic reticulum of the hexose epimers of glucose and mannose. The vast majority of proteins that traverse the secretory are modified by carbohydrates that help control the stability, trafficking and function of proteins. As a large number of disease states are caused by disruptions in protein stability, trafficking or function, understanding how glycans control these properties and processes will provide important insight into a number of human disorders.